Development of Sodium Fluoride PET-MRI for Quantitative Assessment of Knee Osteoarthritis

Project Summary
Osteoarthritis (OA) is the leading cause of disability worldwide. The inability of non-invasive techniques to
quantify disease progression has limited understanding of the pathogenesis of OA. While numerous magnetic
resonance imaging (MRI) methods have been proposed for imaging OA, sensitivity to bone metabolism has
been limited. We propose to develop advanced three-dimensional PET-MRI methods for bone and soft tissue
metabolism to study the response of the tissues in the joint to changes in knee load. This work will lead to a new
understanding of OA pathogenesis by revealing relationships between changes in cartilage and bone
metabolism over time.
This project aims to develop PET-MRI methods to sensitively track changes of OA in response to biomechanical
loading. Our specific aims are to (1) Develop accurate, reproducible and dose-optimized kinetic models of
dynamic 18F-NaF PET-MRI for quantitative bilateral whole joint imaging using deep learning and advanced MR
coil technology, (2) Study the relationship between resting state bone metabolism and biomechanics using PET-
MRI and (3) Perform a longitudinal study to assess the response of our new imaging methods to changes in joint
biomechanics from gait retraining.
The innovation of this work lies in the development of novel imaging techniques that simultaneously offer
quantitative measures of tissue physiology in cartilage and bone using PET-MRI. The significance of this work
is that we will be able to sensitively and quantitatively track changes in bone metabolism and soft tissue
microstructure due to changes in biomechanical loading in the knee joint over time. This will provide new and
more sensitive imaging tools to assess the responses of the joint to biomechanical interventions to treat OA such
as gait retraining, bracing, or high tibial osteotomy.

Public health relevance
Narrative Osteoarthritis affects more than half of the population during their lives and is the leading cause of disability worldwide. Diagnostic imaging of osteoarthritis is often limited to x-ray, but more sensitive and specific imaging is a critical need for assessment of disease-modifying treatments such as bracing or gait modification. This work aims to develop novel 3D imaging approaches using positron-emission tomography (PET) and magnetic resonance imaging (MRI), to quantitatively assess joint health during mechanical treatment of osteoarthritis. !